Exploring Historical Trauma, Racial Discrimination, PTSD, and Substance Use Among Black Young Adults

Project Summary
Overdose deaths are exponentially rising for Black individuals compared to White, where over 50% of
overdose fatalities are associated with polysubstance use. Polysubstance use is a common method of use
among Black young adults, placing them at a greater level of risk for mortality. Racism is a social determinant of
substance use for Black populations and may in part explain some of the observed disparities. Racism is
commonly operationalized and measured as racial discrimination. Racial discrimination measured at its various
levels (i.e., institutional (overt), interpersonal (covert), and internalized) have each been positively associated
with increased substance use. The impact of racial discrimination has been narrowly defined, only accounting
for present-day experiences, and omits the influence of intergenerational, historical influences of racism, or
historical trauma. Historical trauma is conceptualized as losses due to racial and ethnic cleansing, oppression,
and colonization and has been linked to increased substance use among Indigenous youth. Historical trauma
may also serve as an explanation for increased polysubstance use in Black young adults by understanding the
increased vulnerability to racist-related events both present and past. Beyond the strong evidence of the co-
occurrence of posttraumatic stress disorder (PTSD) and substance use disorder (SUD), there is also evidence
that racism-based stressors, like racial discrimination, are also associated with elevated PTSD symptoms among
Black young adults, but little is known about the interplay with historical trauma.
This cross-sectional, quantitative study is unique and novel, as it aims to measure the impact of racism-
related experiences (major discriminatory events (overt), racial microaggressions (covert), internalized racism,
and historical trauma) more comprehensively on PTSD symptoms and polysubstance use among Black young
adults (N = 300), while also psychometrically testing the properties of the adapted Historical Loss Scale. It is
hypothesized that increases in present-day racism-based experiences will be positively related to increased
polysubstance use through PTSD symptoms. Second, the association between present-day racial discrimination
and PTSD symptoms will be moderated by levels of historical trauma. Ultimately, it is hypothesized that the
subjective response to racism-based events may be more pronounced among participants who endorse greater
experiences of historical trauma. The psychometric evaluation will be conducted using confirmatory factor
analysis and testing the associations between historical trauma and psychological symptoms (complex trauma
symptoms, PTSD symptoms, rumination, grief, and anger) to measure construct reliability.
This study revolutionizes the conceptualization of racism as a social determinant of substance use by
including both present-day and historical influences, while focusing on a specific form of substance use,
polysubstance use, that increases risk for fatal overdose. Results from this project can help inform prevention
and intervention efforts targeting at reducing polysubstance use from a culturally sensitive lens.

Public health relevance
Project Narrative This Dissertation Award (R36 Substance Use/Substance Use Disorder Dissertation Research Award (R36 Clinical Trials Optional)) challenges existing conceptualizations of racism-related experiences through an innovative framework that includes historical and present-day dimensions. Historical trauma may intensify traumatic stress-related reactions in response to present-day racial discrimination for Black young adults and may provide critical insight into the observed disparities in polysubstance use risk beyond what a unidimensional approach of racial discrimination can provide. Lastly, the omission of historical trauma in research examining racial discrimination as a risk factor for polysubstance use presents a critical barrier for the development of novel, comprehensive culturally-relevant tools and interventions that effectively reduce polysubstance use in Black young adults.